HazMat Disaster Preparedness Training

CPWR HDPTP Summary/Abstract
This application is being submitted by CPWR-The Center for Construction Research and Training (CPWR) in
response to the Funding Opportunity Announcement, RFA-ES-19-003, Hazardous Materials Worker Health
and Safety Training (U45), for a Cooperative Agreement to support the development of model programs for the
training and education of workers engaged in activities related to hazardous materials and waste generation,
removal, containment, transportation and emergency response.
CPWR is the 501(c)(3) non-profit construction safety and health research and training arm of the North
America’s Building Trades Unions (NABTU), which represents 14 international/national building trades unions
and over 3 million workers. These unions are listed in the Overall Specific Aims section of this Application.
The primary objective of CPWR and its training consortium is to further protect our nation’s workforce from
injuries and exposures that may be encountered in responding to a disaster. Building upon the success of
CPWR’s existing Disaster Response Training (DRT) Program, our goal is to ensure that there are qualified
trainers in place nationally who will train construction workers on a moment’s notice in order to support disaster
response activities.
In partnership with our training consortium building trade unions, the purpose of this grant application is to
seek funding in order to deliver 113 disaster related courses to 1640 apprentices, journey level workers and
trade instructors totaling 18,208 contact hours during Year 1. Over the five-year grant cycle, this proposal will
result in 565 courses, 8,200 students totaling 91,040 contact hours.